Generation of robust resident memory T cells in barrier tissues through skin vaccination

SUMMARY COVID 19, the lower respiratory disease caused by the 2019 nCov virus, is the latest betacoronavirus to cause epidemic disease in humans. Previously, SARS and MERS, both cause by related viruses, emerged and fell dormant as epidemics. Betacoronaviruses use homologous “Spike” proteins to bind mammalian cells for entry and infection, and most vaccines are being built to generate neutralizing antibodies to the unique 2019 nCov Spike protein. In contrast, we are trying to create a “universal” betacoronavirus vaccine base on T cell immunity, using proteins conserved between all known coronaviruses as immunogens. These proteins, expressed by MVA vectors and delivered by epidermal disruption, should provide broad and durable pulmonary immunity to past, present, and future betacoronavirus threats.

Public health relevance
NARRATIVE Vaccines are crucial to the control of respiratory pathogens like 2019 nCov, the virus responsible for COVID 19. Our vaccine uses a new approach, which is designed to provide T cell immunity not only to COVID 19, but also SARS and MERS. Ideally, this vaccine will also provide immunity to betacoronaviruses that emerge in the future to cause infectious epidemics in humans.